Genetic and Molecular Dissection of Regulatory Mechanisms Underlying Temperature and Nutritional Compensation of the Circadian Clock in Neurospora crassa

Project Summary/Abstract:
The circadian clock serves a time-keeping function to anticipate daily changes in the environment and is used
by almost every eukaryote on the planet. The ~24-hour circadian period length is buffered against fluctuations
in external conditions, including temperature and nutrient levels, in a ubiquitous phenomenon called
compensation. The molecular mechanism underlying compensation is not well understood in any eukaryotic
organism. The long-term goal of this project is to understand temperature compensation (TC), nutritional
compensation (NC), and the molecular interactions between compensation effectors and the core clock
network using the model eukaryote Neurospora crassa. Although research and training were significantly
disrupted by the COVID-19 pandemic, the reverse genetic screen for mutants with defects in TC and NC was
completed using the Neurospora knockout collection (Aim 1). The number of mutants with NC defects has
more than doubled because of this work. The mass spectrometry experiments to identify TC-relevant
substrates of Casein Kinase 1 and 2 are well underway, and publication is anticipated in 2022 (Aim 2).
This Administrative Supplement will support additional months of professional development training lost to the
COVID-19 pandemic as well as publication of a third first-author manuscript under this NRSA fellowship.
Molecular mechanisms of circadian compensation are beginning to take shape due to research completed
under this project. This and future independent investigator projects will resolve how the ~24-hour circadian
period length is maintained in the face of different nutrient levels and temperatures in the environment, findings
that have implications for humans with circadian sleep disorders, shift workers, continuous jet-lag, and other
chronobiological conditions.

Public health relevance
Project Narrative: This study will investigate the molecular mechanisms behind compensation of the ~24-hour circadian clock across nutrient and temperature conditions using Neurospora crassa which has long been used as a genetically tractable model system for circadian biology. Due to high levels of functional conservation in circadian clock network components and architecture, findings in Neurospora will directly augment our understanding of circadian rhythms in humans and other eukaryotes. This work has the potential to identify pathways required for proper maintenance of the ~24-hour circadian period length in the face of different nutrient levels and temperatures in the environment, findings that have implications for humans with sleep disorders, shift workers, jet-lag, and other chronobiological conditions.